Effects of binge alcohol drinking on synaptic computing in the nucleus accumbens

The ambition of this proposal is to identify the cellular underpinnings of the early transition
between casual to sustain drinking using drinking-in-the-dark model. We propose to employ
a variety of complementary approaches, including mouse genetics, optogenetics,
behavior and biophysical approaches to test the overarching hypothesis that computing
of the synaptic strength of cortical and amygdala inputs (a phenomenon also known as
synaptic gating) is a mechanism enabling nucleus accumbens medium spiny neurons to
integrate cognitive and emotional information, and is modulated by alcohol exposure to
control consumption. We postulate that this cellular mechanism contributes to the
vulnerability of adolescents to binge drinking.

Public health relevance
Alcohol addiction is a neurological disease that affects millions of individuals in the U.S. and worldwide for which the efficacy of current pharmacological treatments remains limited. To improve such treatments, a better understanding of the long-lasting changes in neuronal communication that occur following chronic alcohol exposure is critical. It has been theorized that the transition from casual to compulsive drinking is driven by poor decision-making, a phenomenon particularly strong during adolescence and whose influence diminishes with age. The initial loss of control over alcohol consumption may be caused by the weakening of the frontocortical-reflective system, and by the concomitant strengthening of the amygdala-impulsive system. The objective of this project is to test the existence of a cellular correlate of this theory in the nucleus accumbens (NAc) by examining how nucleus accumbens medium spiny neurons compute competing cognitive and emotional information coming from the prefrontal and amygdala regions, respectively, and how binge alcohol drinking controls this phenomenon. To explore this question, we will combine in vitro patch-clamp recordings, 2-photon laser scanning microscopy, and a novel double-optogenetics technique in naive and alcohol treated wild-type and transgenic mice.